Web accessible aMR I/fMRI database

DESCRIPTION (provided by applicant): We propose to develop a comprehensive database of simulated aMRI (3D) and fMRI datasets (4D) suitable for use in neuroinformatics tool validation studies. The project will be based upon an existing MRI simulator, MRISIM, which produces highly realistic MRI data, modeling the MRI signal generation, data acquisition process and noise propagation from first principles. The database aspects of the project will expand upon an existing prototype MRI image database and Web interface developed to allow uploading/downloading of MRI data. The proposed project has three specific aims: Aim 1: Enhance the MRI simulator for aMRI and fMRI applications. Aim 2: Create aMRI/fMRI databases of simulated/real data for tool validation. Aim 3: Enhance existing database/file format resources for a large-scale aMRI/fMRI database.